AI and Data Science Core

PROJECT SUMMARY/ABSTRACT – Policy and Systems Science Analysis Core
The primary goal of the Policy and Systems Science Analysis Core (PASSA) of the Washington University
Center for Diabetes Translation Research (WU-CDTR) is to support research focusing on policy assessment,
implementation, systems analysis, and change leading to a reduced burden of diabetes and the promotion of
health equity. This is accomplished through support of leading-edge analytical and modeling methods to reduce
disparities and improve diabetes prevention and management. There is also an emphasis on building new
partnerships and collaborations among policy and systems experts, diabetes scientists, and community
stakeholders. PASSA provides a cohesive structure to deliver services that use policy and systems science
analysis enabling WU-CDTR investigators to enhance the quality and efficiency of their work. PASSA addresses
the large gap between the ability of researchers to link policy and systems interventions to the outcomes and
prevention of diabetes. This gap suggests the need for services to assist in conducting policy and systems
research targeting prevention and self-management of diabetes. By focusing on policy and systems methods,
PASSA will further support diabetes-relevant research across the T2-T4 spectrum and promote translational
research that is more likely to have long lasting environmental impact and produce systems changes that lead to
positive clinical, economic, policy, and health outcomes.
The aims of PASSA are to: (1) improve and expand the use of innovative and state-of-the-art policy
research methods among WU-CDTR investigators; (2) enhance the use of novel systems science methods
among WU-CDTR investigators; and (3) increase the capacity for policy and systems science methods in
diabetes translation research among WU-CDTR investigators.
PASSA has been used to support WU-CDTR investigators conducting diabetes policy and systems
research, analysis, and evaluation. This novel Core has evolved based on input from investigators to better
provide new services to meet a growing demand in the frontier area of systems science research. PASSA now
provides an efficient interface between investigators and comprehensive policy- and systems-analytic research
services that improve the quality of translational research in diabetes and is aligned with WU-CDTR themes of
health equity, dissemination & implementation, and team science.